Bio-Responsive and Immune Protein-Based Therapies for Inhibition of Proteolytic Enzymes in Dental Tissues

SUMMARY
This multidisciplinary proposal translates the efforts of a highly skilled group of researchers forging unprecedented
pathways to promote hard and soft dental tissues preservation. Cutting-edge strategies inspired in approaches used in
the medical field are employed to inhibit selectively endogenous metalloproteinases responsible for mediating the
degradation of the collagen. In Dentistry, the destruction of this essential component of the extracellular matrix is strongly
associated with the progression of periodontal disease and the breakdown of the dental substrate/restorative material
interface leading to bacteria recolonization and recurrent caries, the primary cause of failure of dental restorations. These
pathological conditions together are responsible for almost 80% of the tooth extractions in the United States. In order to
address this serious public health issue, two innovative platforms are proposed. The first strategy is based on the
encapsulation of two potent MMP inhibitors, the polyphenols quercetin and epigallocatechin gallate, in nano micelles
cleavable by MMPs. The shell of the particles is composed of peptides with specific sequences of amino acids recognized
and cleaved by the targeted MMPs, leading to rupture of the micelles and the release of the inhibitor molecules. In
essence, this system enables the MMP to inhibit itself. The second strategy is an immunomodulatory platform based on
the introduction of anti-MMP nanobodies, single domain antibodies derived from llama heavy-chain only antibodies, to
inhibit/cease MMP proteolytic activity. As nanoparticles or nanobodies delivery vehicles, a dental primer formulation and
a newly-designed multifunctional hydrogel are used for the adhesive interface and periodontal pockets, respectively. To
validate the designed platforms, tooth-on-a-chip and animal models are being added in order to fast-track their translation
into clinical care. The innovation of this proposal stems from: (1) the employment of a pioneering approach to inactivate
MMPs in dental tissues based on enzymatic-responsive nanoparticles to deliver inhibitors, and (2) the introduction of a
new paradigm based on the modulation of the MMPs activity by nanobody technology. After completing this project, we
will have these two platforms tailored and validated to be delivered in vehicles compatible with the current clinical
techniques employed to treat periodontitis and to hybridize the dentin during the restorative procedures, which will allow
to bridge the gap between cutting-edge research and improved patient care. In addition, these platforms can be either
combined or tailored in more complex and multi-functional entities and programmed to respond to a variety of enzymes
and cytokines, which provides new opportunities to develop innovative dental tissue regeneration/preservation
therapeutics to minimize tooth loss especially in highly vulnerable population.

Public health relevance
NARRATIVE Collagen degradation mediated by proteolytic endogenous enzymes is strongly associated with the progression of periodontal disease and the breakdown of the dental substrate/restorative material interface, which together are the cause for almost 80% of the tooth extractions in the United States. This project aims to develop two independent cutting- edge platforms based on polyphenols sequestered in enzyme-responsive nanomicelles and nanobodies immune proteins, in order to modulate metalloproteinases (MMPs) -2, -8, and -9 activity in periodontal pockets and at dentin-adhesive interfaces and, ultimately, prevent/cease undesirable dental tissues. It is expected that this proposal leads to the development of biologically-responsive and immunomodulatory-based dental biomaterials capable of suppressing the collagen enzymatic degradation activity in different therapeutic niches while addressing the NIDCR priorities to develop interdisciplinary, unique, and innovative approaches to promote oral health.